Designing Rational Combinations to Improve CAR T Cell Therapy for Prostate Cancer

PROJECT SUMMARY
Chimeric antigen receptor (CAR) T cell therapy is a type of immunotherapy that has shown clinical success in
treating hematological malignancies but faces multiple barriers in the treatment of solid tumors, including an
immunosuppressive tumor microenvironment (TME) that hampers therapeutic responses to immunotherapies
and heterogeneous antigen expression, which reduces the efficacy of CAR T cells that function primarily through
specific targeting of an antigen. Both challenges may be overcome using rationally designed combination
therapies that allow for greater stimulation of innate immunity, T cell infiltration, and CAR T cell efficacy. Our
group has developed CAR T cells targeting the prostate stem cell antigen (PSCA) overexpressed in prostate
cancer and is currently testing them in an ongoing phase 1 trial to treat patients with metastatic castration-
resistant prostate cancer (mCRPC). To further examine the therapy in preclinical models, we developed an
immunocompetent mouse model using mouse prostate tumors that are targeted with PSCA-CAR engineered
mouse T cells. We found that preconditioning tumor-bearing mice with lymphodepleting agent cyclophosphamide
(Cy) beneficially enhanced the TME, allowing for greater intra-tumoral infiltration of both endogenous and CAR
T cells. However, additional modifications are needed to further alter the TME and achieve more durable
responses. To this end, focal radiotherapy (RT) has been found to induce changes in the TME that largely
activate the endogenous immune system and trigger anti-tumor responses by T cells, prompting studies to
combine focal RT with other immune-based strategies. Perplexingly, RT is also known to induce several immune
suppressive effects, which may be particularly magnified in antigen-heterogenous tumor models that limit CAR
T cell efficacy. Using our preclinical model, we plan to develop and optimize this combination of focal RT with
PSCA-CAR T cells to characterize these potentially complimentary therapeutic strategies. We also plan to
unravel these complex effects of radiation on the combination therapy, which will be essential for maximizing the
anti-tumor effects of CAR T cells against prostate cancer. Aim 1: I aim to understand how the immunomodulatory
effects of focal RT on the TME and systemic immunity may synergize with CAR T cells to develop highly effective
treatments against prostate tumors. Aim 2: I plan to identify and overcome resistance mechanisms against this
combination therapy using prostate tumors with heterogeneous antigen expression. With the training and
expertise provided by my research sponsor Dr. Saul Priceman, an expert in developing CAR T cell therapies for
solid tumor treatment, my clinical co-sponsor Dr. Tanya Dorff, the clinical investigator in charge of our phase 1
trial, and the graduate school at City of Hope, an NCI-designated comprehensive cancer center, I will be able to
achieve these goals set forth in this F31 Predoctoral Fellowship application.

Public health relevance
NARRATIVE Chimeric antigen receptor (CAR) T cell therapies for the treatment of solid tumors may be improved by combining with focal radiotherapy to counter the immunosuppressive tumor microenvironment. This combination therapy could be potently effective against both multifocal disease and tumors with heterogeneous antigen expression, which address major challenges faced in the clinic. Thus, my proposed studies for the F31 award to investigate the combination of focal radiotherapy with CAR T cells supports the NIH mission to develop highly effective therapies for solid tumors.